Clinical Pharmacology Approaches towards Accelerating HIV Cure Initiatives

Project Summary/Abstract
For the nearly 37 million people living with HIV (PLWH), functional cure, or antiretroviral (ART)-free remission,
is rapidly becoming an attainable target. While extensive research on the mechanisms underlying immune
dysfunction and viral persistence present promising opportunities for novel therapeutic modalities, a modest
understanding of how pharmacology (pharmacokinetics, PK, and pharmacodynamics, PD) contributes to clinical
variability in reservoir reduction and immune modulation has frequently resulted in marginal clinical trial
outcomes. This career development award will provide Dr. Amelia Deitchman, a pharmacist-researcher with a
PhD in PK/PD, with the essential mentorship and training to develop her independent research program to bridge
this gap in translational HIV cure research by harnessing heterogeneity in drug response and mismatched clinical
translation to further the HIV cure agenda and develop robust and targeted treatments for all patients.
Numerous novel therapeutic approaches are being investigated as components of durable HIV cure,
including immunosuppressants targeting chronic immune dysfunction and inflammation associated with HIV
persistence, as well as broadly neutralizing antibodies (bNAbs) that clear virus and HIV-infected cells. This
research investigates the use of sirolimus alone and with Shingrix (recombinant varicella zoster virus, rVZV
vaccine) in two clinical trials, and two bNAbs in a combination clinical trial. Using data and samples from these
trials in PLWH on virally suppressive ART, and state-of-the-art viral, immune, and pharmacological approaches,
the candidate will 1) establish exposure-response of sirolimus and rVZV vaccine on HIV reservoirs, immune
function and safety, 2) define predictors of sirolimus and rVZV vaccine response variability attributable to PK and
PD heterogeneity, and 3) determine if systemic bNAb levels can predict time to viral rebound after ART
interruption in the context of other curative strategies. We hypothesize that changes in outcomes (reservoir size,
immune phenotype, inflammatory markers, and for bNAbs, reservoir size and time to viral rebound post ART
interruption) are directly related to drug exposure. For sirolimus, these PK/PD relationships may be entirely
distinct from those used for other therapeutic indications. Furthermore, we hypothesize that drug-drug
interactions, and differences in immune genetics, and patient demographic, clinical, and disease-related traits
account for observed variability in clinical drug exposure and response.
Ultimately, this award will be the cornerstone for a career in HIV cure clinical pharmacology research
through hands-on and didactic training in HIV pharmacology, immunology and virology, clinical trials, and grant
writing by an expert team of mentors. These mentors will foster the candidate's development of an independent
academic research career answering clinical pharmacology questions in the setting of HIV cure. The research
performed as part of this award will support a future R01 submission investigating PK/PD relationships to
accelerate drug development, identify novel therapeutic approaches, and deliver precision care to patients.

Public health relevance
Project Narrative Many novel drug treatments are being investigated towards a durable HIV cure, including immunosuppressants targeting immune dysfunction and inflammation associated with HIV infection persistence, as well as broadly neutralizing antibodies (bNAbs) that clear virus and HIV-infected cells. This project will 1) explore how varying exposure to the immunosuppressant, sirolimus, administered with a recombinant varicella zoster virus vaccine, decreases HIV reservoirs and restores immune function, and how patient-specific, genetic, and disease factors may contribute to differences in drug effect, and 2) determine if systemic bNAb levels can predict time to viral rebound after antiretroviral treatment interruption. Overall, this research will help inform dosing in people with HIV and future pharmacological investigations in the HIV cure field.